7-7-Collaborative genomic studies of Tourette Disorder

SUMMARY
See Research Strategy.

Public health relevance
PROJECT NARRATIVE Tourette disorder (TD) is a poorly understood, often debilitating developmental neuropsychiatric disorder, characterized by a combination of persistent vocal and motor tics, affecting between 0.3 to 1% of people worldwide. Our international team of collaborating clinicians and geneticists has established the contribution of new (de novo) variants to TD risk and demonstrated that the continued identification of recurrent de novo variants, via sequencing of the protein coding segment of the genome, is a reliable, systematic path forward for gene discovery. Therefore, our group plans to recruit 1,000 additional parent-child simplex trios, sequence these families, identify additional high confidence TD genes, and begin the process of leveraging these molecular clues to elaborate the biological basis of TD, while making all the collected biomaterials, clinical and genomic data rapidly available to the broad scientific community.